Human Tumor Atlas Network: Data Coordinating Center

Project Summary/Abstract
The Human Tumor Atlas Network (HTAN) seeks to improve our understanding of the important
transitions during tumorigenesis, progression, and metastasis, and to provide a detailed,
multi-dimensional map of these states. Since 2018, our multi-institutional group has managed
the HTAN Data Coordinating Center (DCC), and HTAN data are now available via multiple
mechanisms, including the HTAN Data Portal, the Synapse platform, and the NCI Cancer
Research Data Commons (CRDC). The aim of this application is to continue the important work
of the DCC by continuing to release HTAN data to the wider scientific community and further
developing visualization, annotation, and analysis tools that meet the needs of HTAN and the
diverse cancer research community. Our vision for the HTAN DCC is a dynamic, modular and
adaptive center that will: 1) continue to evolve the HTAN data standards, and continue to build
and maintain the core HTAN data platform for storage, analysis, and dissemination; 2) continue
to provide logistical support for network coordination and communication; and 3) expand our
education and outreach activities to the wider scientific community, further enabling the re-use of
HTAN data.

Public health relevance
Project Narrative The Human Tumor Atlas Network (HTAN) aims to leverage the power of human genome sequencing and other state-of-the-art profiling technologies, to analyze spatial and temporal molecular changes in individual tumors. The HTAN Data Coordination Center (DCC) will ensure that all data generated by HTAN use the same data standards, that all data is hosted in one centralized location, and that all data is shared within HTAN and eventually with the wider scientific community. To maximize the research impact of the data generated, the DCC will also provide powerful analysis and visualization features, and these services and tools will enable researchers to make novel discoveries about the initiation and progression of cancer, as well as the development of resistance to cancer therapy.